Towards Precision Nutrition for Alzheimer's Dementia Prevention: A Prospective Study of Dietary Patterns, the Gut Microbiome and Cognitive Function

PROJECT SUMMARY
This proposal directly addresses a high-priority research topic, “Enabling precision medicine for
Alzheimer’s disease and related dementias through deep molecular phenotyping”, for PAR-19-070, Research
on Current Topics in Alzheimer's Disease and Its Related Dementias, by beginning to develop precision dietary
approaches for AD prevention through integrating multiple molecular data types. The potential for healthy
dietary patterns to maintain cognitive health is supported by cohort studies and a randomized trial. However,
these healthy dietary patterns were developed based on population averages and may not be best suited for a
given individual. Preliminary data from our group and others support the rationale to study personalized
approaches tailored to individual gut microbiomes to improve dietary prevention of Alzheimer’s dementia (AD).
However, no study has examined modifying and mediating roles of the gut microbiome in the diet-cognition
association. The few human studies of the gut microbiome in AD were limited by small size, cross-sectional
design, and lack of high-resolution microbial functional profiling. This background supports our central
hypotheses that 1) healthy dietary patterns contribute to cognitive health partly through modulating the gut
microbiome; and 2) associations of the dietary patterns with cognitive function vary by individuals’ gut microbial
profiles. This proposal represents a highly cost-efficient, prospective study leveraging existing fecal
samples/microbiome data and cognitive function assessments in three studies with complementary strengths
in study design, and diet and outcome assessments: the Nurses’ Health Study II (NHSII, n =1,500) with
decades-long repeated dietary assessments and extended follow-up, the Mediterranean-DASH Intervention for
Neurodegenerative Delay (MIND) Trial with randomized dietary interventions (n =604), and the ASPREE-XT
Study (n =13,000) with adjudicated incident AD endpoints. To gain more advanced mechanistic insights, we
will take a multi’omic approach to combine shotgun metagenomics and metatranscriptomics to profile the
microbial composition and enzymatic function, and fecal metabolomics to measure the microbiome metabolic
activity. We will investigate roles of gut microbial composition and enzymatic function in the associations of the
Mediterranean diet (MedDiet) and the MIND Diet with cognitive function (Aim 1) and examine the
interrelationships among the two healthy dietary patterns, the metabolic activity of the gut microbiome and
cognitive function (Aim 2) in the NHSII. We will replicate findings from Aims 1 and 2 in ASPREE-XT and the
MIND Trial (Aim 3). This project will generate reproducible, translational evidence on gut microbial and fecal
metabolomic features that explain inter-individual heterogeneity in response to healthy dietary patterns and
provide foundational knowledge for maximizing the benefits of dietary approaches, discovering novel predictive
biomarkers, and ultimately contributing to precision prevention of AD.

Public health relevance
PROJECT NARRATIVE Approximately 10% of U.S. adults aged 65+ has Alzheimer's disease and related dementias. This project seeks to identify taxonomic and function features of the gut microbiome and fecal metabolites of microbial origin that explain inter-individual differences in the associations of healthy dietary patterns with cognitive function and risk of Alzheimer’s dementia in three studies of ~1,5000 participants. Based on the unique resources, the proposed research will provide foundational knowledge for maximizing the benefits of dietary approaches, discovering novel biomarkers, and ultimately contributing to precision dietary prevention of Alzheimer's dementia.